Does underrecognition of kidney disease affect patient safety?

DESCRIPTION (provided by applicant): Chronic kidney disease (CKD) is common, but under-recognized, in the health care system, where improving patient safety is a high priority. Poor disease recognition and several other features of CKD make it a high risk condition for adverse safety events. These adverse safety events may include those usually cited for the general population, but also, disease-specific unsafe practices and errors, which in turn, can lead to adverse disease endpoints. Hypothesis: an intervention designed to increase recognition of CKD (a structural measure) will reduce adverse events (outcome measures) by a decrease in the frequency of unsafe medical practices and errors (process measures). Overall aims: 1) We will establish disease-specific process measures reflecting patient safety in CKD (CKD-PSIs) and then measure them in a CKD validation cohort, which will be tracked longitudinally]. 2) [We will evaluate an intervention designed to improve recognition of CKD in a pilot study of CKD patients]. Intervention: An alert system comprised of a CKD med-alert bracelet (or necklace) with a web-based informational link describing the safe care of patients with kidney disease. Study design: a) A consensus-based process intended to establish a set of CKD-PSI linked to disease- specific patient safety, [b) a cohort study of persons with CKD to validate the use of the CKD-PSIs, c) a pilot study of persons with CKD to determine the acceptance and impact of the alert system with longitudinal follow- up to identify preliminary evidence of the efficacy of the intervention on the incidence of CKD-PSIs . Study population: Persons with Stage III - V, pre-dialysis CKD enrolled from a single center with two associated hospitals [validation cohort study: n = 250, pilot study = 100]. Study Measurements: Participants [in both the validation cohort and pilot sample] will undergo baseline and annual in-center visits for medical history and medication review, measurement of renal function (serum Cr for estimation of GFR), follow-up telephone calls [every 4 months between visits] for medical events, and review of hospitalizations (expected duration: from 1 to 3 annual follow-up visits). [Pilot study participants will undergo critical incident surveys at 1 year.] Outcomes: a) [CKD-PSIs (process measures) expected to] include medication errors (e.g., NSAIDs, improperly dosed meds), toxic exposures (e.g., contrast agents, etc), and medical events (e.g., hyperkalemia or hypoglycemia, etc); b) outcome measures including changing renal function, hospitalization, ESRD, and death will also be tracked; c) [acceptance of Med-alert intervention] . Expected findings: Endorsed CKD-PSIs will be feasibly measured and detectable at a significant baseline rate. These CKD-PSIs will show evidence of association with subsequent adverse renal outcomes. The alert intervention will be well tolerated over time and demonstrate indications of a positive impact on the safety of care of patients with CKD. The findings from this study will be instrumental to the development of a randomized controlled trial testing whether increased disease recognition will reduce adverse disease outcomes in CKD via improved patient safety].

Public health relevance
PUBLIC HEALTH RELEVANCE: Chronic kidney disease (CKD) is common, and often goes unrecognized among patients using the health care system where improving patient safety has become a high priority. We will validate the use CKD-specific patient safety indicators and pilot the use of a Medi-alert bracelet and necklace to increase the recognition of CKD, and evaluate its efficacy in reducing the frequency of CKD-specific safety events. Narrative Chronic kidney disease (CKD) is common, and often goes unrecognized among patients using the health care system where improving patient safety has become a high priority. We will validate the use CKD-specific patient safety indicators and pilot the use of a Medi-alert bracelet and necklace to increase the recognition of CKD, and evaluate its efficacy in reducing the frequency of CKD-specific safety events. __SpecificAimsTextDelimiter__ A. Specific Aims Hypothesis: Patients with chronic kidney disease (CKD) have a high frequency of both general and disease-specific safety events that account for a significant proportion of their adverse outcomes. An intervention (structural measure) that increases the recognition of CKD will reduce the occurrence of disease-specific unsafe practices and errors (process measures), and in turn, reduce the incidence of disease-specific adverse events (outcome measures). [Testing this core hypothesis will be a multi-stage process. This R01 application is focused on the set of specific aims, which are prerequisite to the conduct of a multi-center randomized controlled trial (RCT) that tests the effectiveness of an intervention at improving disease outcomes (outcome measures), through reduction in disease-specific safety events (process measures). This project will formulate and validate a set of disease-specific patient safety indicators (process measures) and pilot the use of an intervention intended to increase disease-recognition (structural measure). The results of this effort will be the basis for a multi-center RCT, which tests whether reduction of adverse safety events through implementation of the intervention to increase disease recognition will improve adverse disease outcomes in CKD.] Specific aim 1: Develop and validate array of disease-specific process measures that reflect unsafe practices and errors related to CKD. Patient safety indicators (PSIs) developed by the Agency of Health Care and Research Quality (AHRQ) are intended for the general medical population. In this study, we will establish patient safety indicators which are relevant to CKD (CKD-PSIs). The CKD-PSIs will be validated in a cohort of CKD patients who are observed longitudinally for the detection of these safety indicators. . 1a) Establish a set of candidate CKD-PSIs with the potential to serve as disease-specific process measures reflecting unsafe medical practices in CKD. We will utilize preliminary work and literature review, supplemented by a survey of members of renal community to establish a set of candidate CKD-PSIs which can serve as process measures linked to unsafe medical practices and errors specific to CKD. 1b) Convene a panel of experts to endorse collected CKD-PSIs selected for their use as process measures reflecting unsafe medical practices in CKD. The expert panel will participate in a modified Delphi process to review, rank, modify and endorse established set of CKD-PSIs. This process will ensure face validation of these measures included as key endpoints in the RCT described below. 1c) Validate established CKD-PSIs in a cohort of individuals with CKD tracked longitudinally. We will enroll volunteers from the target population into a cohort tracked longitudinally to detect the incidence of each of the candidate CKD-PSIs, assessing their measurability, and examining the relationship between the occurrence of these safety events and adverse renal outcomes. [Specific aim 2: Pilot a Med-alert bracelet (or necklace) and linked informational website as a structural measure intended to increase the recognition of CKD. A Med-alert system has been devised for the purpose of alerting patients, family members, and providers of a patient's diagnosis of CKD and directing these parties to a website presenting information pertinent to disease-specific patient safety. In this study, this alert system will be modified as needed and piloted in a sample of volunteers (distinct from that assembled for specific aim 1) recruited from the disease population and tracked prospectively. 2a) Pilot the acceptance and utility of a website addressing patient safety in CKD The established website: www.safekidneycare.org will be reviewed and modified by the panel of experts described above and will be presented in a series of focus group of patients from the disease population for comprehensibility and ease of use with further revision. Use of website will be monitored in a pilot sample of patients enrolled from the target population. 2b) Assess the acceptance and efficacy of a med-alert accessory designed to increase recognition of CKD in a pilot sample of participants from the CKD population A pilot sample of subjects will be assembled and followed longitudinally. At one year following enrollment into pilot sample, participants will undergo critical incident surveys to assess their acceptance and use of the med-alert accessory and website and to determine the impact of the alert system on their health care. Regular contacts will be made to monitor tolerance of med-alert accessory, use of website, and to measure frequency of CKD-PSIs.]